Regulation of Adipose Tissue Plasticity by Pericyte GIPR

Project Abstract
Glucose-dependent insulinotropic polypeptide (GIP) is one of two incretins made in the gut and released in
response to food intake. GIP is responsible for communicating with key metabolic tissues to govern the efficient
uptake and metabolism of ingested nutrients. One key target for GIP is adipose tissue, which expresses the GIP
receptor (GIPR) but not the receptor for the second incretin GLP-1, emphasize a potential differentiating
mechanism of action between the two incretins. How GIP regulates adipose tissue metabolism in the
postprandial state is not fully understood and complicating the interpretation of the published literature is a lack
of consensus on which cell type is the target for GIP in adipose tissue. Contrary to the consensus view that the
GIPR is expressed in adipocytes, we have generated several orthogonal data sets that implicate pericytes as the
principal GIPR+ cell type in adipose tissue. Pericytes are specialized cells that line the vasculature with the ability
to regulate several aspects of adipose tissue biology. Importantly, our preliminary data suggests that GIPR+
pericytes represent high-committed preadipocytes, suggesting an essential role in adaptive adipogenesis in
response to various physiological or pharmacological inputs. Based on these data, we hypothesize that GIPR
action in adipose tissue enhances pericyte activity in a manner that supports healthy adipogenesis, enabling the
appropriate storage of excess energy in the context of overnutrition. We have generated several novel tools to
test this hypothesis, including mouse models to support the identification and lineage tracing of GIPR+ cells,
models with selective deletion of GIPR in pericytes, and pharmacological interventions that activate GIPR
function. This MPI grant will leverage the expertise of both the Gupta (adipose) and Campbell (incretins) groups
to thoroughly and rigorous execute the aims of this grant. Completion of this work has direct implications for
understanding the physiology and pathophysiology of adipose tissue in response to weight gain, bring the
importance of adipose tissue pericytes to the forefront, and provide mechanistic insight into pharmacology
therapies that target the GIPR currently being employed to treat type 2 diabetes and obesity.

Public health relevance
Project Narrative Glucose-dependent insulinotropic polypeptide (GIP) is a gut-derived hormone that relays the message of eating to important metabolic tissues to efficiently and appropriately store incoming nutrients. The proposed experiments will test the overarching hypothesis that GIP acts on pericytes, the principal site of GIP receptor (GIPR) expression in adipose tissues, to promote healthy adipose tissue remodeling and optimize nutrient utilization in the setting of overnutrition. Successful completion of this work will provide fundamental insight into how adipose tissue plasticity is controlled while defining new mechanisms of action for GIPR-targeting pharmacology therapies currently employed world-wide to treat type 2 diabetes and obesity.